Neurologic-Informed Care to Improve Health Equity Among Persons with Brain Injury Experiencing Homelessness: A Community-Engaged Implementation Approach

PROJECT SUMMARY
Approximately half of individuals experiencing homelessness or housing instability have sustained at least one
traumatic brain injury (TBI) in their lifetime, with up to 90% having sustained their first TBI prior to becoming
homeless. Becoming unhoused is often precipitated by socioeconomic disadvantage resulting from job loss,
inability to pay medical bills, and/or severing of family ties that provided financial and other supports.
Furthermore, cognitive and behavioral impairments due to TBI can make it difficult to complete tasks of daily
living and maintain key relationships at work and home. When left unidentified and unaddressed, these
impairments can affect a person’s ability to fully benefit from existing homeless and housing service programs
meant to facilitate housing access and housing retention, thus contributing to the chronicity of homelessness
and housing instability. Neurologic-Informed Care (NIC) is a novel, integrated model of care that could enhance
the equitability and effectiveness of services for this population. NIC consists of existing evidence-based
interventions: 1) the Ohio State University TBI Identification Method to screen for lifetime exposure to TBI, 2)
Adult Symptoms Questionnaire for Brain Injury to identify specific impairments, and 3) neurocognitive
accommodations for overcoming these impairments. NIC is a scalable and potentially highly effective model
that can be employed by front-line staff in these settings. NIC is now required by the American Society of
Addiction Medicine when cognitive impairment is an issue, but it is not specific to substance use treatment.
Increasing the uptake, effectiveness, and sustainment of NIC in homeless and housing service settings will
take deliberate, implementation efforts to overcome multilevel barriers at the staff, organizational, and system
levels. Our prior research has demonstrated the utility of implementation blueprints as an effective
implementation strategy for overcoming barriers and scaling-out other interventions in complex treatment
settings, but studies have yet to develop a blueprint for implementing NIC in homeless or housing service
settings. Grounded in the NINDS Social Determinants of Health and Health Equity Implementation
Frameworks, this R34 seeks to address several objectives necessary to prepare for a future hybrid
effectiveness-implementation study aimed to increase the uptake, effectiveness, fidelity, and sustainment of
NIC in homeless and housing service settings nationally. In Aim 1, we will determine client (n = 20) and staff (n
= 15) acceptability of NIC and if adaptations are needed for persons with TBI experiencing homelessness or
housing instability. In Aim 2, we will investigate multilevel determinants to NIC uptake using a convergent
parallel mixed methods design through interviews (n = 25 staff) and surveys (n = 100 staff across 10
organizations in the United States). In Aim 3, we will co-develop an implementation blueprint with our
Community Advisory Board members to address these determinants, connecting specific blueprint strategies to
measurable implementation and effectiveness outcomes.

Public health relevance
PROJECT NARRATIVE Traumatic brain injury is common among individuals experiencing homelessness and housing instability, and often results in cognitive and behavioral impairments that can undermine the effectiveness of existing services, thus contributing to the onset and chronicity of homelessness. Yet, homeless and housing service programs are not implementing recommended, evidenced-based interventions that could improve the equitability and effectiveness of services for these individuals, thereby hindering access to and retention of housing services and supports. This study will investigate the acceptability of our novel, evidence-based Neurologic-Informed Care (NIC) intervention model, assess multilevel barriers affecting uptake of the model, and co-develop an implementation blueprint with our Community Advisory Board to take NIC to scale in a future trial.